Decoding And Targeting The LKB1-AMPK Signaling Pathway In Cancer

PROJECT SUMMARY. The aim of this project is to decode new components of the LKB1 tumor suppressor
pathway to therapeutically target the 15-20% of non-small cell lung cancers (NSCLC) bearing mutations in this
gene. Research over the last 20 years has revealed multiple direct linkages between genes mutated in human
cancer and genes that control cell metabolism. The LKB1 tumor suppressor is a serine/threonine kinase
mutationally inactivated in the familial cancer disease Peutz-Jeghers Syndrome, as well as being the third most
frequently mutated gene in NSCLC, the most common cause of cancer deaths per year. To date, NSCLC patients
with an LKB1 (STK11) mutation fare worse than any other specific genetic subset, exhibiting minimal response
to chemotherapy and other targeted therapies. In recent years, multiple labs have found that STK11-mutant
patients are highly resistant to checkpoint immunotherapies and have minimal therapeutic potential regardless
of mutational burden. Twenty years ago, Dr. Shaw and others discovered that LKB1 directly phosphorylates the
activation loop of the AMP-activated protein kinase (AMPK) and 12 related kinases, turning on their kinase
activity. AMPK is a serine/threonine kinase activated by LKB1 under conditions of low intracellular ATP levels,
after mitochondrial damage, or following loss of glucose or oxygen. AMPK plays a highly conserved role as an
energy sensor and serves to restore metabolic homeostasis by downregulating mammalian target of rapamycin
complex 1 (mTORC1) and parallel anabolic ATP-consuming processes (e.g., lipid biosynthesis), while
upregulating catabolic ATP-restoring processes (like autophagy and fatty acid oxidation). Studies by the Shaw
lab over the past 18 years have sought to understand the mechanistic basis for how AMPK and its related
kinases function by decoding their direct substrates that mediate downstream effects on growth and metabolism.
This may provide actionable targets for therapeutics aimed at this specific genetic LKB1-mutant subset of
NSCLC. The Shaw lab has also used multiple genetically engineered mouse models of NSCLC to perform
preclinical studies with novel cancer metabolism drugs they helped to develop. Building off prior Shaw lab
findings and new clinical insights of LKB1-mutation intractability, two lines of research are proposed. First, a new
in vivo autochthonous CRISPR screening technology will be utilized to directly query the tumorigenic potential
of hundreds of candidate substrates of AMPK and its related kinases to identify those targets that are essential
for tumor growth in Kras:LKB1 (“KL”) but not Kras (“K”) or Kras:p53 (“KP”) mutant tumors. This work builds off
successful phospho-proteomics screens that identified novel substrates of AMPK and the AMPK-related SIK
kinases critical for lung tumor cell survival. Secondly, to address the intrinsic resistance of KL-tumors to
checkpoint immunotherapies, screening will be deployed in combination with biochemical dissection of LKB1
signaling pathway to identify genes that, when deactivated, restore KL-tumors’ responsiveness to checkpoint
immunotherapeutics. Preliminary data demonstrates an unexpected key role for the CREB pathway here.

Public health relevance
PROJECT NARRATIVE Research under this grant is aimed to decode a biochemical pathway all cells use under starvation conditions, which is frequently deregulated in cancer. This starvation pathway contains a gene called LKB1 that is mutated in about 20% of lung cancers, for which there are limited effective treatment options available. By studying normal functions of the starvation pathway in growth limitation and metabolic preservation, new therapeutic targets for treating this common form of lung cancer will be identified and experimentally tested.